Using Glycomic Signatures to Monitor Disease Progression and Predict Treatment Response in Lupus Nephritis

Abstract
Systemic lupus erythematosus (SLE) is one of the most common autoimmune disorders, predominantly affecting
women of childbearing age. Up to half of all lupus patients develop lupus nephritis (LN), a severe kidney disease
characterized by persistent glomerular inflammation and associated with poor health outcomes. Although
urinalysis tests for proteinuria or hematuria are utilized for patient monitoring, their lack of specificity often reveals
significant and irreversible glomerular damage only after its onset. Additionally, conventional markers such as
urinary protein/creatinine ratio (UPrUCr) fail to accurately reflect treatment response, prompting the need for
repeated biopsies to monitor disease progression. Currently, kidney biopsies serve as the primary method for
diagnosing LN and evaluating treatment effectiveness. The goal of this proposal is to identify more sensitive
and less invasive clinical biomarkers for monitoring LN progression and assessing treatment response. The
glycocalyx, comprised of glycoproteins and other molecules, plays a pivotal role in the glomerular filtration barrier
within the glomeruli, which is damaged in LN. Utilizing mass spectrometry-based techniques, our laboratory can
identify specific glycomic patterns in tissues and biofluids, offering a complementary approach to existing clinical
tests for LN detection and monitoring. Given the severity of the pathology in LN the central hypothesis of
this proposal is that glycosylation changes can be detected in urine earlier than conventional markers,
and these unique glycomic signatures can differentiate LN from controls and serve as a noninvasive
predictor of treatment response. In Aim 1, I will evaluate the precision of the distinct glycomic signatures in
identifying LN compared to controls (Aim 1A) and ascertain the efficacy of these unique glycomic profiles in
enhancing the differentiation between complete responders (CR) and non-responders (NR) (Aim 1B). In Aim 2,
I will focus on determining the spatial localization of N-glycans within the kidney (Aim 2A) and identifying their
protein carriers (Aim 2B) using an independent LN cohort with matched serum, urine, and kidney biopsy samples.
Ultimately, this proposal seeks to deepen our understanding of LN pathophysiology, evaluate the predictive
potential of glycomic signatures for disease severity and treatment response in patients, and introduce a less
invasive urine-based approach that can complement current clinical methods to enhance patient care and
outcomes.

Public health relevance
Project Narrative Lupus Nephritis, a severe kidney disease impacting nearly half of all lupus patients, often leads to unfavorable patient outcomes. Existing biomarkers such as the urinary protein/creatinine ratio (UPrUCr) fall short in accurately gauging treatment response, requiring repeating biopsies to monitor disease progression. The goal of this proposal is to assess the predictive potential of glycomic signatures (N-glycosylated proteins) present in the urine of patients with lupus nephritis, offering a more sensitive and less invasive alternative ultimately enhancing current clinical methods and improving patient outcomes.